Cellular/Molecular Mechanisms of Respiratory Neuronal Chemosensitivity

PROJECT SUMMARY
An interoceptive system within the CNS monitors levels of CO2 (or its proxy, H+) and regulates respiratory drive for
rapid homeostatic control of blood gases and systemic acid-base balance; dysfunction of this central respiratory chem-
oreception is cause or consequence of numerous hypoventilation syndromes. Despite recognition of this chemoreflex
system since the early 1900s, and its importance for understanding respiratory (patho)physiology, the identity of the
relevant sensory element(s) remains a point of significant controversy largely because none of the candidate cellular
sensors and molecular detectors have yet fulfilled the requisite experimental criteria. Moreover, the molecular basis
for CO2/H+ sensing, and how those are established developmentally and adapted to pathological conditions, remain
matters of continuing scrutiny. Compelling evidence implicates a discrete group of developmentally specified and
phenotypically characterized neurons located in the brainstem retrotrapezoid nucleus (RTN) as respiratory chemosen-
sors, and suggests that CO2/H+ detection by RTN neurons is mediated by a pH sensitive G protein-coupled receptor
(GPR4) and background K+ channel (TASK-2). However, the evidentiary record remains incomplete. In Aim 1, we
address key remaining shortcomings and test the hypothesis that CO2/H+ sensing by GPR4 and TASK-2 in RTN
neurons is both necessary and sufficient for CO2 stimulation of breathing. We propose to: [1.1] Determine if direct
proton detection by TASK-2 accounts for its effects on RTN neuronal CO2/H+ sensitivity and CO2-stimulated breathing;
[1.2] Examine CO2-sensitive breathing after re-expression of wild type and pH-insensitive GPR4 or TASK-2 in RTN
neurons of knockout mice; and [1.3] Establish by in vivo photometry if CO2-induced modulation of RTN neuron activity
requires GPR4 and TASK-2 in conscious mice. In Aim 2, we test the hypothesis that neuroadaptive mechanisms in
RTN neurons account for changes in the respiratory chemoreflex associated with physiological and pathological chal-
lenges. We propose to: [2.1] Examine mechanisms and consequences for birth-related PACAP expression in early
postnatal RTN neurons; and [2.2] Characterize neuroadaptation of RTN neurons and the chemoreflex during persis-
tent excessive chemosensory stimulation (chronic CO2 elevation, as in chronic obstructive pulmonary disease). For
both aims, we apply multi-scale analyses in novel genetic and disease mouse models to examine: behavioral/func-
tional outcomes at the whole animal and cellular levels by plethysmography, photometry, and in vitro electrophysiol-
ogy; and we determine adaptive changes in gene expression using single neuron molecular analyses.
Collectively, the proposed studies will: 1) interrogate the remaining criteria for RTN neurons to fulfill rigorous evi-
dentiary requirements for their classification as bona fide respiratory chemosensors; and 2) define molecular and
cellular mechanisms for RTN neuronal adaptation in response to (patho)physiological challenges, with relevance for
identifying potential cellular and molecular targets for treating disorders of breathing.

Public health relevance
PROJECT NARRATIVE An interoceptive mechanism monitors brain CO2/H+ levels to regulate breathing and rapidly control blood gases and systemic acid-base status; dysfunction of this homeostatic chemosensory reflex accompanies clinically serious hypoventilation syndromes (e.g., sudden infant death, congenital central hypoventilation) and various chronic disorders of breathing associated with elevated CO2 (e.g., chronic obstructive pulmonary disease). A population of Phox2b+/Nmb+ neurons in the brainstem retrotrapezoid nucleus (RTN) are believed to subserve a critical CO2/H+- chemosensory component of this reflex, but important evidence required to support that contention remains unavailable. In addition, it remains to be determined whether and how adaptive changes in RTN neurons might contribute to the blunted chemosensory reflex observed with developmental and disease-related disorders of breathing. Here, we deploy mouse genetic and disease models, combined with single cell electrophysiological and molecular characterization, to definitively address outstanding evidentiary requirements for RTN neurons as critical respiratory chemosensors, and to characterize neuroadaptive changes in chemoreflexes and RTN neurons during the vulnerable early neonatal period or COPD-like chronic CO2 exposure.